Core D: Administration

SUMMARY The overall goals of the Administrative Core (Core D) are to provide central leadership to foster productive research interactions and a high degree of integration between projects and cores, and manage/coordinate all scientific, administrative, regulatory and fiscal responsibilities of the Program.

Public health relevance
NARRATIVE This essential Core will ensure efficient leadership and management of the Projects and Cores, which will lead to productivity and the integration of the Program Project Grant with high degree of interactions between basic mechanistic and translational studies to target the pro-survival S1P signaling for improving treatment outcome of patients with advanced solid tumors.